Development of peptide drug conjugates for cancer therapy

Abstract
The ultimate goal of this project is to develop and commercialize peptide drug conjugates to treat life-
threatening triple negative breast cancer. Triple negative breast cancer (TNBC) is a high aggressive
subtype of breast cancer with poor survival. TNBC patients do not respond well to currently available
clinical therapies, including targeted therapy. Chemotherapy is commonly used to treat TNBC. We will
develop novel peptide conjugates of chemotherapeutics for highly efficient and tumor-specific delivery of
the anticancer drugs into triple negative breast cancer. Various drug delivery systems, including
nanosized delivery systems, have been tested for delivery of anticancer therapeutics for treating TNBC.
However, these delivery systems are unable to provide efficient drug delivery in solid tumors due to the
physical barrier of dense tumor extracellular matrix (ECM). Previously, we have designed and developed
a small peptide targeted MRI contrast agent ZD2-N3-Gd(HP-DO3A) (MT218) to target an ECM
oncoprotein extradomain B fibronectin (EDB-FN) for accurate detection of TNBC. MT218 is able to
deliver the contrast agent at micromolar concentrations in aggressive tumors, including TNBC, resulting
in robust signal enhancement for accurate detection of triple negative breast cancer in mice with MRI.
Currently, MT218 is in phase II clinical development for cancer diagnosis. In this project, we will design
and develop ZD2 peptide targeted drug conjugates for efficacious treatment of TNBC. The specific aims
are: 1) to synthesize and characterize a peptide drug conjugate to treat triple negative breast cancer; 2)
to determine in vivo therapeutic efficacy of the drug conjugate to treat TNBC in mouse models. After
further demonstrating the feasibility of the peptide drug conjugate in tumor models, including a PDX
model, in this phase 1 SBIR project, we will then further perform comprehensive preclinical assessment
of its physicochemical properties, pharmaceutical properties, and therapeutic efficacy for further clinical
development. The peptide drug conjugate has a great potential to achieve highly efficient, tumor-specific
drug delivery and efficacious treatment of triple negative breast cancer and to improve the quality of the
life and survival of the patients.

Public health relevance
Project Narrative The project will focus on development and commercialization of a novel peptide drug conjugate with highly efficient, tumor specific drug delivery for effective treatment of triple negative breast cancer. Comprehensive preclinical assessments of the peptide drug conjugate will be performed to enable clinical development. Successful outcome will result in effective treatment of triple negative breast cancer.